Frontiers in Stem Cells and Regeneration Course

Project Summary: Pluripotent stem cell biology and regenerative medicine are rapidly growing fields with
enormous biomedical implications across the entire spectrum of NIH’s clinical, translational, biomedical and
behavioral portfolios. This R25 application seeks five years of sponsorship for our advanced training course
entitled: Frontiers in Stem Cells and Regeneration (FrSCR) held annually at the MBL in Woods Hole under the
Co-Directorship of Drs. Jennifer Morgan (MBL) and Ina Dobrinski (University of Calgary). FrSCR has been
funded for the past five years as a new R25 award, and prior to that under U13 and T15 mechanisms. FrSCR
continues to build on its demonstrated strengths and successes, and continues to expand to incorporate
emerging, important biomedical concepts and sophisticated technological breakthroughs in regeneration and
pluripotency.
The FrSCR course introduces participating trainees to state-of-the-art research in the fields of
pluripotent stem cell (PSC) biology and regenerative medicine, including biology and applications of
multipotent adult stem cells (ASC). We provide trainees the necessary knowledge of laboratory techniques,
career mentoring and instruction in the ethical, legal, and societal impact (ELSI) of PSC research to greatly
enhance their successful entry into this field. In order to achieve this goal, we propose the following specific
aims: 1) to provide in-depth instruction on the fundamental concepts in stem cell biology and regeneration; 2)
to provide hands-on laboratory training in cutting-edge methods for experimentation with stem cells and
regeneration; 3) to educate trainees on the open questions in the field, and how stem cells and regenerative
biology can be used to solve problems related to human developmental, reproductive, aging, and neurological
disorders, among others; 4) to provide opportunities for career planning and advancement, and to educate
trainees on the legal, ethical, and regulatory landscape in which regenerative medicine research occurs, and
5) to foster a diverse, collegial environment, and to provide students with networking opportunities that lead to
long-term interactions, mentorship, and collaborations.
FrSCR is a dynamic and evolving entity that each year offers a fresh series of daily lectures on
emerging concepts, followed by extended discussions, laboratory research, technologically intense workshops
and informal seminars over a week-long period. The course is directed towards established investigators as
well as advanced fellows and newly independent scientists who are committed to fundamental, translational or
clinical research studies. The course addresses major current problems, followed by critical discussions and
laboratory experiments in which advanced new techniques are presented to explore these problems. Thus, this
course will provide a significant benefit to biomedical research through the training of new investigators in the
field of stem cell biology and regeneration.

Public health relevance
Narrative – Public Health Relevance The use of pluripotent stem cells for regenerative medicine holds enormous potential for understanding the root causes of diseases, as well as designing innovative strategies for treating a host of human disorders. However, this rapidly growing field is in need of highly trained scientists with expertise in stem cell biology, regeneration, and the technological methods for their applications in regenerative biology and medicine. The Frontiers in Stem Cells and Regeneration Course at the Marine Biological Laboratory in Woods Hole, MA promotes advances in the field by bringing together scientific experts and students in an advanced, hands-on training course, thus enhancing the training of the next generation of highly skilled stem cell scientists.